Developmental Research Program

PROJECT SUMMARY/ABSTRACT
The purpose of the Developmental Research Program (DRP) of the MSK SPORE in Prostate Cancer is to
support innovative translational research projects in prostate cancer. This program will allow us to respond
quickly to new opportunities in translational research. Through the DRP, we will provide seed funding for
innovative, investigator-initiated research in the etiology, prevention, diagnosis, and treatment of prostate
cancer; fund research with exceptional potential to advance the translational research goals of the SPORE with
timely response to new research opportunities, and establish a mechanism for strategic interactions with other
SPOREs and other major national and international research centers
The Executive Committee will prioritize pilot projects for support based on novelty and programmatic need
resulting from the Committee’s review of work presented at our research meetings, including the Prostate
Cancer Working Group (weekly), SPORE Scientific Seminar Series (monthly), Genitourinary Disease
Management Team (monthly), Multi-institutional Prostate Cancer Program Retreat (annual), and the MSK
Geoffrey Beene Cancer Research Center Retreats (annual). This ensures the steady infusion of new ideas and
techniques into our SPORE in Prostate Cancer program. Preference will be given to projects that complement
the long-term research goals of the SPORE and advance our translational research objectives. The Executive
Committee can also solicit and fund experimental or clinical initiatives that address an urgent and specific need
in the MSK SPORE in Prostate Cancer program or a unique research opportunity.